Hospital GamePlan4Care: A Web-Based Delivery System for Dementia Caregiver Support

This is a Mentored Physician-Scientist Award in Alzheimer’s Disease and Related Dementias (ADRD)
application for Dr. Molly Horstman, a hospitalist and health services researcher at the Michael E. DeBakey VA
Medical Center, who is establishing herself as a young investigator at the intersection of hospital medicine,
dementia, and caregiving. This award will provide Dr. Horstman with the necessary support (1) to develop
expertise in ADRD and dementia caregiving, (2) to receive formal training in implementation science research
methods, and (3) to gain the experience needed to establish herself as an independent physician-scientist. To
achieve these goals, Dr. Horstman has assembled a multidisciplinary mentoring team of nationally recognized
investigators in ADRD, Dementia Caregiving, Geriatrics, and Implementation Science research methods.
Hospital admissions are sentinel events for Veterans with ADRD and their family caregivers. Adults with
ADRD are often discharged from the hospital with new functional and cognitive limitations, which increases
demands on family caregivers following discharge. These changing caregiver demands increase caregiver
stress, which can lead to worse outcomes for caregivers and care recipients. Over 20 years of research has
demonstrated that care transitions interventions started in the hospital can improve outcomes for patients.
Furthermore, care transitions interventions started in the hospital and designed specifically to meet the needs
of stroke caregivers have been shown to reduce caregiver burden and anxiety and reduce acute care resource
use following discharge. To date, this evidence base supporting tailored interventions to meet specific
caregiver needs has not been translated to the support for dementia caregivers during care transitions.
Resources for Enhancing Alzheimer’s Caregiver Health (REACH II) is a multicomponent, evidence-based
ADRD caregiver support program that has been adapted and implemented in the Veterans Health
Administration as REACH VA. When delivered in the community, REACH II and REACH VA were associated
with improvements in caregiver depression, caregiver social support, and caregiver self-care and a decrease in
caregiver burden and problem behaviors in the care recipient. Evidence-based interventions, like REACH II,
are challenging to scale and spread due to the need for one-on-one interactions between caregivers and
dementia care specialists for skills training. GamePlan4Care (GP4C) is a novel, web-based training platform
designed to fully replicate the core components of REACH II in an acceptable and scalable online platform
informed by user-centered testing. With adaptation to the hospital setting to include care transitions training,
GP4C has great potential to transform the support of ADRD caregivers during care transitions.
This proposal will combine evidence-informed care transitions training with an existing dementia caregiver
support intervention to create a new and unique intervention: Hospital GP4C. Using a Planned Adaptation
Approach, we will build on the existing GP4C platform to incorporate the robust evidence supporting tailored
care transitions training and support. The aims are to: 1) adapt GP4C for hospital care (Hospital GP4C), 2)
evaluate the feasibility and acceptability of the Hospital GP4C intervention, and 3) to evaluate caregiver-
reported outcomes and retention rates in a pilot randomized study of Hospital GP4C compared to health
education. In Aim 1, semi-structured interviews with caregivers and staff will be used to inform the planned
adaptation of GP4C for hospital care. Human-centered design will be used to develop care transitions specific
content to supplement existing GP4C content. In Aim 2, quantitative and qualitative data will be collected to
assess the feasibility and acceptability of Hospital GP4C. In Aim 3, a single site pilot randomized study of
Hospital GP4C compared to a health education control will be conducted. Caregivers will be recruited in the
hospital. The results of this award will inform a VA Merit Award for a multisite randomized controlled trial of
Hospital GP4C.

Public health relevance
Hospital admissions are challenging for adults with dementia and for the family and friends who care for them. Following hospital discharge, adults with dementia often have increased care needs, which places new demands on their family and friends. Family and friends are critical to ensuring that Veterans with dementia can live safely in the community following discharge. Healthcare systems have an opportunity to support family and friends of adults with dementia by addressing dementia specific caregiving challenges that arise during the transition from hospital to home. However, there are no support interventions for dementia caregivers that have been developed or tested as part of hospital care. In this proposal, we will design and test a novel support intervention for the family and friends who care for hospitalized Veterans with dementia. This proposal aligns with the research priorities of the Veterans Health Administration and the National Institute on Aging to identify strategies to support the family and friends who provide care to adults with dementia across care settings.